Exploring T. pallidum Pathogenesis in the Placenta Using Novel In Vitro Models of Syphilis During Pregnancy

PROJECT SUMMARY
A rapid rise in syphilis cases has caused cases of congenital syphilis, the second leading cause of stillbirth
worldwide, to skyrocket. Despite its prevalence, very little is known about the mechanisms through which
Treponema pallidum (Tp), the causative agent of syphilis, is able to invade the placenta, impact placental
function, and cause adverse pregnancy outcomes. This is largely due to a complete lack of viable in vitro models
to study pathogenesis of Tp in the placenta. The overall objective of this proposal is to use novel in vitro models
to investigate mechanisms through which Tp invades and impacts the placenta. By combining expertise from
the Mysorekar and Edmondson/Norris laboratories, Tp has successfully been cultured in vitro in trophoblast cells
and this system is being adapted to work with 3D stem cell-derived trophoblast organoids (SC-TOs). This project
investigates the hypothesis that pairing these new in vitro models with an integrative, multi-omic approach will
allow identification of key pathways and targets underlying placental invasion and replication of Tp at the
maternal-fetal interface. Aim 1 will further define the optimal conditions for co-culturing Tp with Jeg-3 cells and
SC-TOs. Advanced microscopy techniques will be used to characterize Tp attachment, growth, and possible
internalization and migration of various Tp strains in our models. Aim 2 will elucidate the metabolic alterations
and nutrient siphoning mechanisms that occur during Tp infection. Unbiased metabolomics will be conducted on
trophoblasts infected with Tp to identify changes in trophoblast nutrient and metabolite levels due to host nutrient
siphoning by Tp. Western blotting, immunofluorescence, and confocal imaging will then be used to examine
changes in the expression and localization of nutrient transporters which regulate materno-fetal nutrient
allocation across the placenta. Aim 3 will use integrated multi-omics to explore mechanisms underlying and
driving Tp infection of trophoblasts by identifying changes in chromatin accessibility, gene expression, and
protein expression elicited by infection. Bioinformatics will be used to integrate these -omic outputs and identify
overarching pathways altered in trophoblast cells by Tp. Together, these studies will begin to identify key
mechanisms through which Tp infects the placenta and impacts trophoblast function. This will be integral to
increasing basic understanding of Tp pathogenesis in the placenta and for identifying novel biomarkers and
treatment targets for syphilis-associated pregnancy outcomes.

Public health relevance
PROJECT NARRATIVE The rapid rise in congenital syphilis cases poses a critical public health challenge, as this infection can lead to severe complications, including stillbirth and lifelong health issues for infants. Understanding how the syphilis- causing bacterium, T. pallidum, crosses the placenta and affects fetal development is essential for developing better prevention and treatment strategies. The proposed work will address these questions by using multi-omics and innovative in vitro models of the placenta to identify mechanisms of T. pallidum action and potential targets for intervention to help reduce adverse pregnancy outcomes and improve maternal and infant health globally.